Polyamine blockade and anti-tumor immunity in head and neck squamous cell carcinoma

PROJECT SUMMARY/ABSTRACT
This proposal describes a four-year Career Development Plan (CDP) to prepare R. Alex Harbison, MD to
become an independent physician-scientist focused on targeting polyamine (PA) metabolism to increase
immune responses to head and neck squamous cell carcinoma (HNSC). There is an urgent need to identify
less toxic, targeted therapy for HNSC. Leveraging the immune system to treat HNSC is a promising approach
to decrease morbidity, although the response rate is limited due, in part, to immunosuppressive PA levels
in the tumor microenvironment (TME). PAs are a family of small polycations important for immune cell
homeostasis. T cells require PAs for activation (i.e., via RNA translation and chromatin regulation) and
differentiation (T helper subsets). However, PAs are enriched in the TME which impairs 1) anti-tumor T cell
function and antigen-presentation by dendritic cells, and 2) supports immunosuppressive myeloid cells. PAs
are 15-fold higher than normal in HNSC. Inhibition of both PA synthesis and uptake, known as PA blockade
therapy (PBT), has dual effects on immunity. It can promote anti-tumor immune responses while also
decreasing inflammation in autoimmune mouse models. Thus, the overall objective of this proposal is to
define the mechanisms through which PAs modulate anti-tumor immunity. The central hypothesis is that
dysregulated PA metabolism in the TME diminishes anti-tumor T cell responses which can be therapeutically
targeted. The specific aims of this proposal are 1) to test mechanisms through which extracellular PAs
mediate T cell responses and antigen-presentation in the TME and 2) to evaluate the effect of PBT on cos+
T cell and immune responses in the TME. The proposed studies will utilize quantitative histology and
spatially resolved mass spectrometry imaging, T cell culture and co-culture with tumor cells and dendritic
cells, metabolomics and carbon tracing, PA transporter knockout, and in vivo murine HNSC models to
evaluate the effect of PA metabolism on anti-tumor immune responses. The mentors, Ors. Peng, Patti, and
Puram, will primarily oversee the CDP providing training on immune cell signaling and development, gene
knockout in primary immune cells, animal models in immunology research, and metabolomic measurements.
The Research Advisory Committee will add complementary expertise in systems immunology, innate
immunity and nutrient utilization, and metabolic regulation of immune function. This group is the ideal forum
to chaperone the candidate's progression as a physician-scientist. The training plan includes achievement
of technical expertise, grant writing skills, responsible conduct of research, and mentorship though direct
experience in the lab, seminars, workshops, coursework, and presentations at national/international
meetings. Immersion in the research milieu of Washington University given its extensive track record,
resources, and commitment to physician-scientists provides the ideal training environment. This K08 will
provide the Pl necessary skills to obtain research independence.

Public health relevance
Head and neck cancer treatment suffers from significant morbidity and often low response rates. To identify novel, less-toxic treatments, this proposal will determine how polyamines, a family of targetable small polycations with immune regulatory functions affect the anti-tumor immune response. This K08 Mentored Clinical Scientist Research Career Development Award application describes the skills, training, and research plan that the Pl, Dr. R. Alex Harbison, will require over the next four years to become an independent physicianscientist studying polyamine regulation of anti-tumor immunity in head and neck cancer. Project Narrative